FY232 FACILITIES TO G-B1073 MOLD REMEDIATION

Building 1073 is a repository for the Natural Products Group and Division of Cancer
Treatment and Diagnosis (DCTD). It houses approximately thirty-three LN2
Freezers as well as walk in freezers, administrative and lab space. Building
conditioning issues resulted in the formation of mold throughout the space. This
project will update the HVAC system for Building 1073 and remediate the entire
building. The administrative and lab portion of Building 1073 will be demolished as
the first phase of the project. This area will have a temporary LN2 piping system
installed along with the other required mechanical and electrical upgrades. The
existing LN2 freezers in Building 1073 will be relocated to that area of the building
prior to construction commencing in the remainder of Building 1073. Upon
completion of the construction throughout the remainder of the building, the freezers
will be relocated back to the repository warehouse portion of the building and the
administrative and lab area construction will be completed.